Toward portable microchannel artificial lungs for veteran rehabilitation

? DESCRIPTION (provided by applicant): The long-term goal of this technology development project is improve the rehabilitation of veterans suffering from lung diseases through the development of the first truly portable, biocompatible, artificial lung capable of short and long term respiratory support. Current artificil lungs have recently been used to rehabilitate lung disease patients; however, significant advances in gas exchange, biocompatibility, and portability are required to fully realize their potential. Microchannel artificial lungs promise to enable a new class of truly portable artificial lungs through feature sizes and blood channel designs that closely mimic those found in their natural counterpart. Our small-scale microchannel artificial lungs achieved the highest gas exchange efficiency of any artificial lung to date. Their lifetimes were improved through the application of custom, biocompatible surface coatings. The objectives of the current Merit Review proposal are to: 1) Increase the membrane area and rated flow of our microchannel artificial lung by a factor of 100X; 2) Further increase the biocompatibility of our microchannel artificial lung through nitric oxide release; and, 3) To perform initial gas exchange and lifetime studies in animals. These objectives are critical to advancing this promising technology towards initial acute systems for veteran pulmonary rehabilitation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic obstructive pulmonary disease (COPD) affects approximately 16% of the veteran population. COPD is the fourth most prevalent disease in the VA population and one of the most costly to the VA health care system. Over 500,000 service-connected respiratory disabilities have been diagnosed in veterans and 6.5% of all Gulf War service-connected disabilities are respiratory system related. Operation Enduring Freedom and Operation Iraqi Freedom Veterans have been exposed to chemicals known to cause acute and chronic respiratory conditions including CARC paint and chromium dust. Other veterans have experienced acute lung and failure from blast injury or smoke inhalation. Over 2.3 million veterans reported having some form of "lung trouble" in the 2001 National Survey of Veterans. This project has the potential to revolutionize the rehabilitation of veterans suffering from lung disease through the development of a truly portable, biocompatible, artificial lung.